Core A: Administrative Core

CORE A: PROJECT SUMMARY
The Administrative Core (Core A) is critical to the success of the Yale SPORE in Skin Cancer (YSPORE). The
primary purpose of the Core is to support and facilitate transdisciplinary research efforts in skin cancer and identify
new challenges and opportunities as they emerge. The Administrative Core serves as the central coordination
point for YSPORE investigators, with responsibility for monitoring the progress of all projects and cores toward
a translational/clinical endpoint. These services include provision of (a) fiscal management, (b) clerical and
organizational support, (c) mechanisms for internal and external review, (d) support for enhancement of scientific
interactions and collaborations among the Project/Core leaders, (e) mechanisms to monitor projects and cores
for scientific progress, (f) coordination of outreach efforts, and (g) mechanisms to expand research in skin cancer
beyond the activities of the SPORE, both within Yale and outside of Yale. Core A will also be responsible for
ensuring full integration of activities of the Yale SPORE in Skin Cancer with those of Yale Cancer Center and
the other Yale SPOREs, with the goal of avoiding overlap and duplication of efforts while maximizing synergy
and use of resources. Any conflicts that might arise between SPORE investigators will be addressed by the Core
A Directors, with input from the Executive Committee and the External and Internal Advisory Boards and Eric
Winer, MD if needed. Core A will work closely with the Biostatistics and Bioinformatics Core (Core C) to ensure
the integration of data generated by the SPORE program into that of Yale Cancer Center and vice versa, and to
oversee sharing of data with other skin cancer/melanoma SPORE sites, and when appropriate, with the Yale
SPORE in Lung Cancer and the Yale Head and Neck SPORE. Core A will organize joint scientific research in
progress meetings held with the SPORE researchers, to ensure bi-directional flow of ideas and sharing of
resources. Investigators involved in this program will also participate in the annual inter-SPORE workshops,
organized by Core A in collaboration with Administrative Cores at other sites. The Core will be directed by Drs.
Marcus Bosenberg and Harriet Kluger and the Co-Director is Dr. Mario Sznol. Program oversight by Core A will
be done with input from the Executive Committee, and input for scientific and administrative functions will be
sought from the Internal and External Advisory Boards. Annual meetings with the Internal and External Advisory
Boards will be organized by Core A. The Core will also organize research in progress seminars, talks by outside
investigators, and patient and community outreach.